Mechanisms associated with organotropic metastasis

ABSTRACT
Most cancer patients with solid tumors die of metastatic disease and organotropic spread is an understudied aspect
of metastasis, for which new insights are urgently required. The prevailing ‘seed and soil’ concept posits that
permissive environment in a distant organ (soil) is necessary to support the survival and growth of lurking tumor
cells (seeds). Induction of permissive soil in a non-metastatic organ is proposed to re-route metastasis; however,
rigorous experimental evidence and mechanistic analyses are lacking. Fibrotic tissue alterations, including
inflammation, provide cues for metastasis, together with the signals from bone marrow-derived cells (BMDCs),
the tumor secretome, and circulating extracellular vesicles. Our preliminary data suggest organotropic metastasis
is not solely dependent on permissive matrix remodeling and BMDCs in the secondary organs, but is also
contingent on the disruption of vascular endothelial barrier function imposed by organ-specific vascular junction
proteins. Our findings lead to a central hypothesis that ‘vascular heterogeneity functionally contributes to
organotropism of metastasis’. We propose studies to unravel the mechanisms, by which distinct fibrotic niches
effect organ-specific changes in the vascular beds, leading to organotropic metastasis. Preliminary studies
identified angiopoetin-2 (Ang-2) as a putative mediator of lung metastasis. We aim to unravel the mechanisms of
Ang-2 dependent tropism to the lung but not the kidney or liver, which also generate high Ang-2 levels in the
fibrotic setting. Using single-cell RNAseq and CyTOF, we will determine the cellular and molecular targets of
Ang-2 in the pre-metastatic milieu. Preliminary studies show Ang-2 induces vascular leakage in the lung
vasculature without impacting kidney or liver vessels, thus directing metastasis to the lung. Exosomes released
by the fibrotic organs also increase vascular permeability and metastatic colonization in the lung, without affecting
kidney or liver vasculature. Single-cell RNAseq of fibrotic organs, as well as genetically engineered mice
(GEMs), will be used to unravel the rate limiting effect of tissue-specific disruption of Ang-2 in breast cancer
metastasis. Using novel GEMs generated in the lab, we will trace lineage-specific production of metastasis-
inducing exosomes and identify the determinants of organotropism via proteomic analysis. Our preliminary
studies show Ang-2 disrupts vascular barriers through repression of claudin-5 that is found exclusively in the lung
vasculature, in contrast with the kidney and liver vessels, which present with multiple, redundant endothelial
claudins. Integrating mouse models with endothelial-specific deletion of claudin-5 and claudin-5 reporter mice,
and with molecular profiling of organ-specific endothelial cells in loss- and gain-of-function experiments, we will
elucidate functions of specific claudins in organotropic metastasis. Molecular studies will be performed to identify
putative mechanism of Ang-2 mediated suppression of claudin-5 and test whether manipulation of vascular
permeability can re-route metastasis regardless of cancer-specific organ predilection. Successful completion of
the proposed studies will provide new insights into mechanism of metastasis and therapeutic implications.

Public health relevance
PROJECT NARRATIVE Our preliminary findings show the tropism (preferred homing) of metastasis to specific secondary organs is not solely dependent on the permissive matrix remodeling and immune suppressive environment, but is also contingent on the vascular heterogeneity, specifically organ-specific expression of endothelial junction proteins that enable vascular barrier function. Here we propose to test whether vascular heterogeneity functionally contributes to organotropism of breast cancer metastasis. Using novel mouse models and cutting-edge technologies for single-cell analysis, we aim to unravel cellular and molecular mechanisms that regulate metastasis to specific organs and explore novel therapeutic targets.